Laboratory Flexible Funding Model (LFFM) - Nebraska Department of Agriculture

FDA Laboratory Flexible Funding Model (LFFM) RFA-FD-25-007
Other Project Information (Overall) – Project Summary Abstract
Nebraska Department of Agriculture Laboratory
The Nebraska Department of Agriculture (NDA) Feed, Fertilizer, & Agricultural Lime (FFAL)
Laboratory is seeking funding under the FDA funding opportunity RFA-25-007, "Laboratory
Flexible Funding Model (LFFM)”. The NDA FFAL Laboratory is committed to working with the
FDA to enhance the capacity and capabilities of state human and animal food testing
laboratories to support the overall goal of an integrated food safety system (IFSS). The NDA
Regulatory Program and NDA FFAL Laboratory support the goals and aims of this funding
opportunity.
Our Research Strategy will describe how the NDA FFAL Laboratory meets the eligibility
requirements of this funding opportunity. The research plan will also demonstrate that the NDA
FFAL Laboratory is competent and has the capability to achieve the program requirements and
goals outlined in the funding opportunity. The NDA FFAL Lab will use the grant funding to
perform 100 chemical analyses on animal food products through the Chemistry Analytical Track,
B2 – Animal Food Product Testing. The funding would continue to support the overall goals of
the NDA and FFAL Laboratory by protecting the animal food supply in Nebraska.

Public health relevance
FDA Laboratory Flexible Funding Model (LFFM) RFA-FD-25-007 Other Project Information (Overall) – Project Narrative Nebraska Department of Agriculture Laboratory In alignment with the Integrated Food Safety System (IFSS) and the objectives of the Food Safety Modernization Act (FSMA), the FDA continues to enhance laboratory testing capabilities that support regulatory efforts in human and animal food safety. This proposal seeks to strengthen collaboration between the FDA and state and local laboratories by supporting and expanding food safety and food defense testing. During this project, the Nebraska Department of Agriculture – Feed, Fertilizer, & Agricultural Lime (NDA-FFAL) Laboratory aims to generate high-quality, actionable testing data that supports regulatory investigations and the removal of contaminated products from commerce.